Investigating roles for oxidative guanine damage in transcription regulation

Project Summary/Abstract
Excess reactive oxygen species (ROS) arising from endogenous sources and environmental exposures, such
as air pollution, chemicals and smoking, can cause oxidative stress, a detrimental condition linked to age-related
diseases and cancer in humans. Oxidative stress damages the entire cell, but is markedly harmful for DNA, with
the lesion 8-oxoguanine (8oxoG) being particularly prevalent. Cells adopt multiple mechanisms to maintain
homeostasis, including mutagenesis prevention and transcriptome reprogramming. Guanine-rich sequences are
enriched at telomeres and regulatory regions of the genome and are therefore, hot spots for 8oxoG formation.
Telomeres, the nucleoprotein caps which protect linear chromosomes, are transcribed into long non-coding
telomere repeat-containing RNAs (TERRA). 8oxoG formation and base excision repair processing at regulatory
sequences, have been implicated in gene expression regulation. However, elucidating the mechanisms of
transcriptional modulation by 8oxoG remains challenging, because oxidants used to induce oxidative stress
damage multiple cell components and generate diverse DNA adducts. Our group validated a fluorogen activating
peptide (FAP) system which produces singlet oxygen when bound to a photosensitizer dye and excited with far-
red light, converting guanine into 8oxoG. We report 8oxoG production at telomeres with high spatial and temporal
control by fusing the FAP with telomere protein TRF1. For this proposal, FAP has been adapted to target 8oxoG
to specific promoter sequences (dead Cas9-FAP) or genome-wide (H2B-FAP). The goal of this proposal is to
test the hypothesis that the processing of 8oxoG in G-rich genomic regions and promoters regulates
transcriptional responses to oxidative genotoxic damage. During the mentored K99 phase, Aim 1 will delineate
how 8oxoG damage at telomeres regulates the dynamics of TERRA transcription, stability and epigenetic
modifications, and how these changes affect telomere homeostasis. During this phase, I will take advantage of
resources at the University of Pittsburgh for professional development, to apply these skills through research,
data presentation, and writing opportunities. During the independent R00 phase, I will apply technical skills
obtained from additional training with key collaborators and models validated during the K99 phase to elucidate
how 8oxoG regulates transcription of specific oxidative stress-responsive genes at the endogenous loci in cells
(Aim 2, dCas-FAP). Also, during this phase I will extend these approaches genome-wide, employing RNA-seq,
OG-seq and ChIP-seq to elucidate the coupling between 8oxoG processing and gene expression in response to
singlet oxygen produced at chromatin (Aim 3, H2B-FAP). These experiments will provide me with the data
required for an early independent publication and preliminary data for research proposals. Importantly, during
the R00 phase I will develop independence from my mentor by focusing on the dynamic interplay between 8oxoG
repair and gene expression regulation.

Public health relevance
Project Narrative Oxidative stress emanating from endogenous sources and genotoxic environmental exposures is a causative agent of DNA damage that is linked to inflammation, age-related diseases and cancer in humans. This proposal will utilize a novel tool to induce singlet oxygen mediated base damage in human cells specifically at telomeres, at endogenous gene promoters or throughout the genome, to study the specific impact of 8-oxoguanine lesion processing on the regulation of transcriptional responses to genotoxic oxidative damage. The project is therefore relevant to understand the crosstalk between repair of oxidative damage and gene expression, and their role in human disease.